Target-Specific Dyes with Responsive Long-Lived Fluorescence Lifetimes for Biological Interrogation

Abstract/Project Summary
The fluorescence lifetime of a dye can inform about cellular signaling, protein-protein interactions, and membrane
microenvironments with fluorescence lifetime imaging microscopy (FLIM) and time-resolved flow cytometry (TR-
Flow Cytometry). These techniques primarily use changes in the fluorescence lifetime from Föster-Resonance
Energy Transfer (FRET) dye pairs to convey biological information occurring within a 10-nm distance. In addition,
FLIM is often used to circumvent biological autofluorescence by producing an image based on the differences
in the fluorescence lifetimes of a dye. However, the fluorescence lifetimes of archetypal dyes are short (< 3 ns),
and their minimal lifetime changes upon biological stimuli cannot be resolved with these instruments, limiting the
extent and precision of biological interrogation during their operation. The goal of our program is to synthesize,
characterize, and implement a palette of target-specific organic dyes with biologically-responsive long-lived
fluorescence lifetimes, primarily by incorporating thermally activated delayed fluorescence (TADF) photophysics.
Of biological relevance is that these organic dyes can yield two long-lived fluorescence lifetimes that are
mechanoresponsive, thermoresponsive, and sensitive to voltage. Therefore, we hypothesize that concomitant
changes in the fluorescence lifetime of our optical reporting dye technology will be easily resolved with FLIM and
TR-Flow Cytometry and inform us of viscosity, polarity, and voltage changes associated with biological function.
In addition, this TADF dye technology can potentially extend the Föster resonance distances of the FRET dye
pairs, opening new frontiers for interrogating biomolecules separated by distances > 10 nm.
Of relevance is sensing cholesterol, as its levels impact membrane viscosity. Our preliminary data demonstrate
that a TADF dye can sense cholesterol levels in liposomes, as its fluorescence lifetime increased from 9.4 ns to
13 ns when cholesterol levels were increased from 0% to 20%. Contrarily, a constant fluorescence lifetime of ~
2.6 ns was obtained for DI-8-ANEPPS, a cholesterol-sensing dye. Notably, a long-lived fluorescence lifetime of
711 ns was detected for the TADF dye in giant multilamellar vesicles (GMLVs) that was not clearly detected in
liposomes. These results are significant, as these lifetime increments are easily resolved with fluorescence
lifetime measurements and are a goal for dye synthesis. A plausible explanation is that the lifetime differences
between GMLVs and liposomes are due to membrane curvature differences, confirming that TADF dyes can be
used to inform membrane morphology. Building on these findings, we are synthesizing a palette of TADF dyes
that fully intercalate into membranes, target the mitochondria and important organelles, and serve as
bioconjugates for biological interrogation with FLIM and TR-Flow Cytometry. To achieve this objective, our
program combines previous success in organic dye synthesis, photophysical characterization of organic TADF
dyes, and biophysical interrogation in artificial and living systems. Our program can have applications in medical
diagnostics, cellular trafficking, and other biological research beyond the immediate scope of this initial work.
1

Public health relevance
Project Narrative Our research program aims to develop a dye technology that exhibits long-lived fluorescence lifetimes so that changes in their fluorescence lifetimes induced by biological stimulus can be resolved with FLIM and time- resolved flow cytometry. To achieve this objective, our program will combine previous success in (1) the synthesis of organic dyes, (2) time-resolved photophysical characterization of organic dyes with TADF photophysics, and (3) biophysical interrogation of these dyes in artificial and living systems. Successful implementation of this dye technology will advance fundamental biomedical research by leveraging data and methods and developing experimental technologies to study macromolecular, organelle, and cellular structure and function. 1